Label-free, live-cell classification of neural stem cell activation state

Project Summary
Neural stem cells (NSCs) in the brain proliferate and generate newborn neurons throughout life. Dysfunctions
in neurogenesis have been associated with neurological diseases such as epilepsy, depression, and Alzheimer’s
Disease. A significant rate-limiting step in adult neurogenesis is NSC quiescence exit, when a non-dividing
quiescent NSC (qNSC) enters the cell cycle prior to population expansion and differentiation. Further, during
aging and disease, extrinsic and intrinsic factors drive NSCs deeper into quiescence, reducing neurogenesis,
and contributing to cognitive decline. Therefore, identifying factors controlling NSC quiescence and quiescence
exit are critical to improving neurogenesis and enhancing cognitive function.
Currently our understanding of NSC quiescence is incomplete due to technical limitations imposed by the
bias of markers used to isolate each population of NSCs and the lack of live cell labeling strategies. However,
recently we observed distinct optical signatures separating activated NSCs (aNSCs) from qNSCs using
fluorescence-lifetime imaging (FLIM) and the relative abundance of two signals: 1) the metabolite NAD(P)H, and
2) autofluorescence within lysosomes (PAF), a technique we refer to as optical cell state imaging (OCSI). OCSI
is a non-invasive tool capable of tracking NSC cell state in living cells over time, without exogenous label. OCSI
collects 2 types of data from each cell: the relative abundance of NAD(P)H and PAF through fluorescence
intensity, and a decay rate of fluorescent photons from NAD(P)H and PAF using FLIM. This decay rate can
change based on fluorophore binding to protein partners or chemical state, which is dependent on the metabolic
pathways used by a given cell. Importantly, many studies have shown that qNSCs and aNSCs preferentially rely
on different types of cellular metabolism for generating energy. Using dimension reduction analyses of the 8
measures collected with OCSI in young mouse NSCs, we have not only identified distinct signatures separating
qNSCs and aNSCs and tracked the dynamic changes of these measures through live cell imaging during
quiescence exit, but also prospectively sorted NSCs based on this autofluorescent signal to successfully predict
their proliferative behavior and identity from in vitro cultures and acutely isolated NSCs. These results reveal
OCSI as a novel tool that uses the energetics of a cell to define its cell state, allowing us to unbiasedly address
unanswered questions about NSC quiescence and activation to advance our understanding of these processes.
We here propose to 1) identify the molecular signal associated with PAF, one of the primary contributors to
OCSI’s predictive ability, 2) determine which quiescent populations current methods of NSC identification target,
and 3) develop a FLIM-based cell sorter and single cell deposition system to increase the throughput for future
studies while maintaining the high-resolution separation of quiescent to activated cell states. Completion of these
Aims will provide a novel tool and establish OCSI as a method to answer critical questions regarding the
mechanisms and regulators underlying NSC quiescence that can be targeted to drive NSC proliferation.

Public health relevance
Project Narrative Cognitive decline, associated with aging and neurological disease, limits the quality of life and independence of a large portion of our aging society. This decrease in cognitive function is correlated with a decreased production of newborn neurons in the hippocampus, due in part to neural stem cells becoming more quiescent in these conditions. To overcome current technical limitations in the field, we here propose a novel imaging method to better detect and study quiescent neural stem cells, thus i) providing critical knowledge of the molecules and regulators that define and drive quiescent cell states and ii) identifying potential targets to enhance neurogenesis.